Modeling Health Equity and Economic Impacts of National Strategies to Address Food and Nutrition Insecurity

PROJECT ABSTRACT
With worsening food insecurity in the COVID-19 pandemic and rising food prices, a 2022 White House initiative
sought to address diet-related diseases (e.g., obesity, diabetes, cardiovascular disease) and disparities through
food and nutrition insecurity interventions. However, Policymakers lack critical evidence on the effects of
promising interventions to address food and nutrition insecurity because of no available evidence on long-term
population health, effects on health disparities, and cost-effectiveness. This proposal seeks to fill these gaps by
improving our understanding of the health equity and economic effects of different food and nutrition interventions
and providing important evidence to support national priorities around diet-related diseases and health disparities.
Based on three criteria: (a) strategies outlined in the 2022 White House report, (b) conceptual framework based
on a health impact pyramid and NIMHD research framework regarding the domains of influence (population- vs.
individual-based), and (c) availability of supporting evidence, we have identified four highly promising
interventions to address food and nutrition insecurity: (1) expanding the USDA-supported Gus Schumacher
Nutrition Incentive Program and (2) expanding the SNAP benefits and eligibility, (3) accelerating uptake of
food/nutrition security screening and (4) enhancing access to nutrition/obesity counseling. Using our NIH-funded,
validated, state-of-the-art, and dynamic microsimulation model, this project will measure the longer-term health
outcomes, health equity, and economic impact of these four highly promising policy interventions to address food
and nutrition insecurity on the US adult population and across racial/ethnic and socioeconomic groups. Through
robust sensitivity and scenario analyses, our analytic framework allows us to examine the heterogeneous effects
of these diverse interventions on long-term effectiveness and cost-effectiveness across population subgroups
and whether such heterogeneous effects reflect differences in baseline risks (e.g., food insecurity) or vulnerability
to the risk (e.g., effects of food insecurity on outcomes) or intervention’s effects across subgroups. Our innovative
approach and multidisciplinary expert research team uniquely position us to measure long-term population health
effects of food and nutrition insecurity interventions (Aim 1), estimate long-term effects on health disparity across
population subgroups of food and nutrition insecurity interventions (Aim 2), quantify economic effects and cost-
effectiveness of food and nutrition insecurity interventions (Aim 3). An independent dissemination aim will
improve knowledge translation to end-users by conducting legal and administrative feasibility analysis and
developing a web-based interactive platform (National Food and Nutrition Policy Impact Simulator).
With the growing need for more robust evidence to address food and nutrition insecurity, our project will
generate policy-relevant evidence on optimal policy choices that may depend on how different interventions
affect long-term population health, certain key groups (i.e., reducing disparities), and overall cost-effectiveness.
Using such evidence, policymakers can prioritize evidence-based national food and nutrition policies.

Public health relevance
PROJECT NARRATIVE Policymakers lack critical evidence on the effects of promising interventions to address food and nutrition insecurity because of no available evidence on long-term population health, effects on health disparities, and cost-effectiveness. Using our NIH-funded, validated, state-of-the-art, and dynamic microsimulation model, this project will measure the longer-term health outcomes, health equity, and economic impact of four highly promising policy interventions to address food and nutrition insecurity on the US adult population and across racial/ethnic and socioeconomic groups. This proposal seeks to fill these gaps by improving our understanding of the health equity and economic effects of different food and nutrition interventions and providing important evidence to support national priorities around diet-related diseases and health disparities.